Dietary regulation of anti-tumor immunity through caloric restriction

ABSTRACT
OVERALL OBJECTIVE: The food we eat can affect tumor growth. Yet, it is unclear whether diets that alter
nutrient levels in the tumor microenvironment (TME) primarily impact cancer cells or instead impact immune
cells that provide critical defense against tumor progression. We have found that reducing overall calorie
intake by 30–50%, a dietary regimen known as caloric restriction, antagonizes tumor growth by
boosting anti-tumor immunity. Caloric restriction profoundly impacts the fate and function of CD8 T cells in
the TME, favoring the activity of tumor-controlling T effector (Teff) cells while minimizing the accumulation of
dysfunctional or “exhausted” T (Tex) cells. By studying how caloric restriction steers CD8 T cells between
effector and exhausted fates, we will identify novel diet-regulated mechanisms that underpin CD8 T cell-
mediated anti-tumor immunity and thus gain mechanistic insight into the epigenetic, transcriptional, and
metabolic networks that link diet, lipid metabolism, and cancer progression.
HYPOTHESIS: That the availability of ketone bodies versus fatty acids in the TME is a critical
determinant of anti-tumor immunity. Our preliminary data indicate that caloric restriction antagonizes tumor
growth by boosting anti-tumor CD8 T cell responses. These effects are lost when CD8 T cells cannot process
ketone bodies, providing a mechanistic link between diet-regulated nutrients (ketone bodies) and anti-tumor T
cell function. While caloric restriction and other diets can increase circulating levels of ketone bodies, some of
these diets also increase circulating levels of fatty acids, which we hypothesize can negate or diminish the
positive impact of ketone bodies on anti-tumor immunity. Our working model is that the balance between
circulating levels of ketone bodies and fatty acids impacts ketone body-dependent metabolism and epigenetic
programming in CD8 T cells and, by proxy, the balance between functional Teff cells (providing anti-tumor
immunity) and dysfunctional Tex cells (dampening anti-tumor immunity) in the TME.
SPECIFIC AIMS: (1) Determine how dietary fats influence anti-tumor T cell responses in the context of caloric
restriction; (2) Determine how caloric restriction differentially controls T cell metabolism in the TME; and (3)
Define how caloric restriction influences CD8 T cell fate decisions in the TME.
IMPACT: Upon completion, this proposed research will have determined the mechanisms by which caloric
restriction boosts CD8 T cell-mediated anti-tumor immunity, not only increasing the function of Teff cells but
also decreasing the accumulation of dysfunctional (or “exhausted”) Tex cells in the TME. Our work will have
laid the groundwork for defining dietary interventions with the power to boost the efficacy of immune checkpoint
inhibitors (ICI) and diminish and/or reverse cancer progression.

Public health relevance
PROJECT NARRATIVE Our proposed research will define how diet mechanistically steers immune cell fate and function to boost anti- tumor immunity and inhibit tumor growth. By defining how anti-tumor immune responses are impacted by diet- induced changes in circulating levels of ketone bodies versus lipids, the proposed research could be transformative, allowing us to better understand the impact of diet on cancer progression and leverage this knowledge to improve cancer immunotherapies. Findings from these studies will provide concrete pre-clinical evidence for future studies assessing how specific diets that alter lipid metabolism can synergize with immunotherapies to improve cancer outcomes.